Mechanisms of cohesin regulation in vertebrates

Abstract
In vertebrate cells the cohesin protein complex plays critical roles in nuclear structure and
function. It tethers together the identical products of DNA replication, called sister chromatids,
until cell division and it also mediates intra-chromosomal bridging interactions, forming
chromosome loops and domains. While cohesion between sister chromatids is critical for
accurate chromosome segregation and certain kinds of DNA repair, the compaction of
chromosomes into loops and domains is essential for proper transcription and normal
development. How these different kinds of cohesion differ at the molecular level, the
mechanisms that ensure each outcome, and the amount of overlap between them are not well
understood. Using molecular genetic approaches, we are testing the impacts of specific
interactions, in multiple experimental systems, on cohesin regulation. In this application we are
requesting supplemental funds to purchase an ultra-low (-80) freezer in which to store strains,
cell lines, and proteins. Our current freezer has broken down and can no longer be repaired.
This freezer is essential for us to complete the projects described in the parent proposal.

Public health relevance
Here we are requesting an equipment supplement to purchase a new ultra-low freezer to use in performance of the projects described in the parent grant. Use of this new freezer is essential to our ability to work in an efficient manner. This work is relevant to NIGMS’s mission to support basic research that increases our understanding of biological processes and lays the foundation for advances in disease diagnosis, treatment, and prevention.